Integrin alpha v beta 3 promotes resistance to EGF receptor inhibitors

DESCRIPTION (provided by applicant): Integrin αvβ3 is expressed in the most aggressive and metastatic cancers. Here, new experimental data suggests that αvβ3 also drives a novel pathway of resistance to EGFR-targeted therapies. In fact, different epithelial carcinoma cell lines exposed to the EGFR inhibitors erlotinib or lapatinib for several weeks show enhanced expression of the integrin ß3 subunit in the subpopulation of surviving cells. Mechanistically, αvβ3 integrin promotes the plasma membrane clustering of oncogenic K-Ras to drive its signaling to RalB and its downstream effectors. This αvβ3/K-Ras/RalB oncogenic unit not only increases anchorage-independence in vitro and tumor growth in vivo, but it also renders tumors resistant to EGFR inhibition. These findings suggest that disabling components of this novel pathway may enhance the sensitivity to EGFR-targeted therapies. Experiments outlined in this proposal will examine the significance of the αvβ3/K-Ras interaction in terms of EGFR inhibitor resistance for a number of epithelial cancers in vitro and in vivo. The goal of Aim 1 is o define the structural basis for the association between integrin αvβ3 and K-Ras, which appears to drive RalB- mediated signaling in epithelial carcinoma cells. Studies in Aim 2 are designed to determine which ß3/K- Ras/RalB effectors drive anchorage-independence and erlotinib resistance, and to test both genetic and pharmacological strategies to block this pathway in vitro. Finally, Aim 3 will evaluate strategies to overcome EGFR inhibitor resistance for subcutaneous and orthotopic mouse cancer models. If successful, these studies will support the continued use of EGFR-targeted therapies in the clinic, and offer novel strategies to improve response to such therapies once tumors acquire resistance.

Public health relevance
PUBLIC HEALTH RELEVANCE: Although a number of EGF receptor inhibitors are approved to treat various epithelial cancers, de novo and acquired resistance mechanisms are common and limit the use of these drugs. We have identified a novel pathway in which integrin αvβ3 expressed by a variety of epithelial cancers not only represents a marker of EGFR inhibitor resistance but does so by coupling to and activating K-Ras/RalB. Understanding the mechanism by which αvβ3 drives EGFR inhibitor resistance will allow us to develop novel strategies to sensitize a range of tumors to EGFR-targeted therapies.